Path A Oregon Department of Agriculture's Cooperative Agreement for Continued Implementation of a Produce Safety Program

Oregon Project Summary / Abstract
The Oregon Department of Agriculture (ODA) is applying for Path A non-
regulatory Education and Inventory Funding for Band 3 of PAR-21-174
under the project title Oregon Department of Agriculture’s Cooperative
Agreement for Continued Implementation of a Produce Safety
Program under Path A. ODA’s Produce Safety Program implements the
Food and Drug Administration (FDA) Food Safety Modernization Act
(FSMA) Produce Safety Rule (PSR) through education, outreach, technical
assistance and the development of a farm inventory. ODA’s proposed
project will increase understanding of and compliance with the PSR,
ultimately resulting in increased food safety and quality of Oregon produce.
The development and implementation of the program began in the previous
Cooperative Agreement’s 5-year cycle and will continue under the
expectations outlined in the current PAR-21-174. Oregon’s Produce Safety
Program will provide outreach and education to 1,554 produce operations
by June 30, 2026 and to have our farm inventory of 1,554 farms, 100%
verified by June 30, 2026. We will continue to offer On-Farm Readiness
Reviews and other technical assistance to covered Oregon operations via
either remote or in-person assistance. Our program will work in cooperation
with FDA as they conduct routine Produce Safety Rule inspections in
Oregon. We will also continue to meet the reporting requirements to FDA
as established in PAR-21-174. Work resulting from this funding will help to
minimize the risk of foodborne illnesses associated with Produce Safety
Rule covered produce and activities.

Public health relevance
Project Narrative The Oregon Department of Agriculture (ODA) project entitled: Oregon Department of Agriculture’s Cooperative Agreement for Continued Implementation of a Produce Safety Program under Path A intends to build upon the current Produce Safety Program in Oregon over the next five years by providing education, outreach and technical assistance to produce farms in Oregon while continuing to build Oregon’s farm inventory. The project will utilize federal funds in accordance with the objectives in FOA PAR-21-174. Efforts funded through this project will help produce farms in Oregon comply with the Produce Safety Rule, thereby reducing the likelihood of foodborne illness from fresh produce grown, harvested, packed or held on Oregon operations and support further integration into a national Integrated Food Safety System.